Aligning the Alliance of Genome Resources with FAIR and TRUST principles

PROJECT SUMMARY The Alliance of Genome Resources (the Alliance) is a “knowledge commons” for expertly curated genomic data and annotations by model organism databases (MODs) and the Gene Ontology Consortium (GOC). Our mission is to facilitate the use of model organisms to understand human biology and disease. The Alliance is organized as two interconnected functional units: Alliance Central and Alliance Knowledge Centers. Alliance Central is responsible for development and maintenance of the software platform and shared modular infrastructure and for the coordination of data harmonization activities across the Knowledge Centers. Alliance Knowledge Centers such as the MODs and the GOC are responsible for expert curation and for submission of data to Alliance Central using common data formats. Knowledge Centers also are responsible for organism- specific user support activities, resources, and user access to data not yet supported by Alliance Central. The data management principles of the Alliance align well with the principles represented by FAIR principles (Findability, Accessibility, Interoperability, Reusability) and operational approaches reflected in the TRUST principles (Transparency, Responsibility, User focus, Sustainability and Technology). The focus for the administrative supplement in response to NOT-OD-21-089, includes the following aims: (1) address areas of improvement documented for the Alliance of Genome Resources (Alliance) in a FAIRShake assessment conducted under the auspices of the NIH Common Fund Data Ecosystem Project, (2) complete the Alliance's application to obtain Core Trust Seal certification, and (3) update information about the data and annotation licensing terms at the Alliance hosted on the (Re)usable Data Project (RDP). We will also participate in the workshops and meetings described in NOT-OD-21-089 which will allow the Alliance to compare the metrics/indicators we use to evaluate the impact of our resource to those of other relevant data resources and to adapt our metrics as needed to conform to new community standards or trends. The outcomes of the proposed work align well with the intent of NOT-OD-21-089 to increase the compliance of community data resources with FAIR and TRUST principles that are foundational to a modern data science ecosystem for the biomedical research community.

Public health relevance
PROJECT NARRATIVE The Alliance of Genome Resources (the Alliance) is a “knowledge commons” for expertly curated model organism data and annotations obtained from multiple model organism databases (MODs) and the Gene Ontology Consortium (GOC). The primary goals for this administrative supplement request are to (1) improve FAIR compliance by addressing issues identified in a FAIRShake assessment conducted under the auspices of the NIH Common Fund Data Ecosystem Project, (2) complete the Alliance's application to obtain Core Trust Seal certification, and (3) update information about the data and annotation licensing terms at the Alliance hosted on the (Re)usable Data Project (RDP).